MULTIMEDIA--TRAINING FOR EFFECTIVE CANCER COMMUNICATION

The long term objective is to develop an innovative product for health professionals to help them overcome some of the difficulties associated with cultural differences, language differences and low-literacy in the delivery of cancer prevention and control initiatives. Specific aims of Phase I are to: (1) evaluate how to best adapt the capabilities of interactive health communications technology to the cancer prevention and control needs of providers serving low-literacy Hispanic populations; (2) develop such technology for the purpose of improving the effectiveness of health professionals serving these populations; (3) prepare a complete design document for the product to be developed in a Phase II effort. Such an application of multimedia technology would utilize state-of-the-art communications technology to provide training and guidance to health professionals working with hard to reach populations.